Elucidating the molecular basis of lncRNA evolution for mammalian dosage compensation

ABSTRACT
Genetic sex determination and sex chromosomes have evolved in both animals and plants. In mammals,
males are XY and females are XX. Degeneration of the Y chromosome and the difference in the number of X-
chromosome would lead to dose imbalance of X-linked gene products between male and female cells. To resolve
this problem, various dosage compensation mechanisms have evolved in heterogametic species. In mammals,
one of the two X chromosomes is transcriptionally silenced in females during X-inactivation. While X-inactivation
has been extensively studied as a paradigm for epigenetic regulation of sex chromosomes, it is largely controlled
by long noncoding RNAs (lncRNAs) that remain elusive for their role in the evolution of dosage compensation
mechanisms. In general, human lncRNAs impact early development and affect human disease. However,
whether lncRNAs represent “byproducts” of transcription or essential biomolecules in gene regulation, e.g. X-
inactivation, has been under continuous debate. Experimental models for functional lncRNA and evolution of
RNA-mediated mechanisms are scarce.
Our research focuses on a cluster of lncRNA genes functional for X-inactivation. This cluster of lncRNA
genes have evolved concomitantly on the X chromosome, from ancestral protein-coding genes through
pseudogenization and gain of RNA functions, coincidental with the evolution of X-inactivation along the
divergence of eutherian and marsupial mammals. Our recent data have demonstrated that, within this gene
cluster in the mouse genome, the lncRNA Jpx activates lncRNA Xist and functions as a molecular switch for
mouse X-inactivation. We have also reported, by comparing mouse and human homologs, functional
conservation of Jpx in X-inactivation despite overall sequence and RNA structural divergence. But questions
regarding 1) what sequence variations are determinant of lncRNA function for X-inactivation, 2) are there
regulatory features of lncRNA essential for X-inactivation, 3) what drives the function of Xic locus in X-
chromosome silencing, are unresolved. These are questions directly related to the evolution of dosage
compensation in mammals. In this project, we will (1) determine the regional sequence motifs of Jpx lncRNA that
are essential for its function in X-inactivation, (2) determine whether both trans and cis activities of Jpx lncRNA
are necessary for its function in X-inactivation, and (3) understand the function of Xic in chromosome silencing
and the requirement of its cis and trans activities by integrating the Xic sequence into an autosome. The proposed
research is anticipated to uncover insights into the molecular features of lncRNA for function in X-inactivation,
which will contribute to our understanding about not only lncRNA evolution, but also dosage compensation
evolution in mammals.

Public health relevance
PROJECT NARRATIVE / RELEVANCE This project seeks to investigate the molecular function and evolution of long noncoding RNAs (lncRNAs) in mammalian gene regulation, in particular, X chromosome dosage compensation. Abnormalities in dosage compensation and dysregulation of lncRNAs have been linked to many human developmental disorders and diseases including cancer. Research findings from this proposal will provide essential knowledge for applying lncRNAs in health diagnostics and will contribute to new methods for targeted disease therapies and prevention.